The role of ERRalpha/PGC-1 in disease pathogenesis

DESCRIPTION (provided by applicant): The Estrogen Related Receptor alpha (ERRα) is an orphan nuclear receptor whose transcriptional activity is regulated by the expression level and/or activity of its obligate coregulators PGC-1α or PGC-1β. Under normal physiological conditions, the ERRα/PGC-1 complex is involved in regulating metabolic homeostasis in tissues in which energy demand is high. Motivated by the observation that elevated expression of ERRα in both breast and ovarian tumors is associated with a poor clinical outcome, we developed a gene signature (metagene) that permitted a quantitative evaluation of ERRα activity in tumors. Using this tool, it was determined that ERRα activity is manifest in all breast tumor sub-types with particularly high activity being evident in ERα-negative, HER2 positive, and triple negative breast cancers where it predicts a negative outcome. A causal role for ERRα in breast cancer growth was confirmed in both cellular and xenograft models of breast cancer. Interestingly, it was also demonstrated that growth factor and/or PI3K-dependent activation of ERRα/PGC-1 induces the expression of genes required for metabolic reprogramming in transformed cells and genes involved in angiogenesis, metastasis, and the establishment of the tumor microenvironment. Hypothesis: We propose that growth factor/oncogene-mediated upregulation of PGC-1α and/or PGC-1β expression results in the ERRα-dependent activation of processes that contribute to tumor growth and metastasis. Specifically, it is hypothesized that this receptor contributes to cellular biomass accumulation by inducing the expression of key gene products required for the generation of biosynthetic intermediates and those which enable the adaptive responses underlying the differential use of glucose and lactate by cells in different tumor environments. ERRα further reinforces these metabolic responses by regulating processes involved in (a) the establishment and maintenance of the tumor microenvironment, (b) angiogenesis, and (c) facilitating distant site metastasis. Specific Aims Aim 1: Define the rol of ERRα in the metabolic reprogramming associated with breast tumor progression. Aim 2: Define the role of ERRα in establishing and maintaining the tumor microenvironment in breast cancer. Aim 3: Define the impact of ERRα on growth and metastasis in established models of breast cancer. Expected outcomes: Our data suggests that inhibition of ERRα may have utility in the treatment of ERα- negative, HER2 positive, and triple negative cancers where its activity is particularly evident. The studies outlined will advance this therapeutic approach by defining the importance of ERRα as an integrator of cancer cell metabolism and of other non-metabolic pathways of pathological importance in cancer. We believe that the metabolic pathways upregulated by ERRα in cancer are also manifest in healthy tissues with a high metabolic demand, and, thus, the insights from this work will be instructive as to the role of ERRα in normal physiology.

Public health relevance
PUBLIC HEALTH RELEVANCE: Elevated expression of the nuclear receptor ERR� in breast tumors has been shown to be associated with poor clinical outcomes. It is of significance, therefore, that inhibition of ERR� expression/activity effectively reduces the growth of both ER�-positive and ER�-negative tumors when propagated as xenografts. Building on this observation we propose to define the mechanisms by which ERR� impacts breast cancer pathogenesis and define the specific processes regulated by this receptor that are amenable to therapeutic intervention.